HOSTING, MAINTENANCE AND PROFESSIONAL SERVICES FOR RAVE AND MEDIDATA RAVE INTEGRATED ANCILLARY SOFTWARE FOR NCI'S CANCER THERAPY EVALUATION PROGRAM (CTEP)

The Contractor shall provide the Parent IDIQ SOW Tasks (Task Areas) 1, 2, 3, 4, and 5 as further described below:

a) Hosting (Task 2) and maintenance (Task 3) for Rave-Classic (or RaveEDC), and TSDV for active trials conducted by the NCI multi-center program. Trial activity is based on database action during the prior month (ex. data capture, query, export).
b) Note: NCI is currently using Rave-Classic for majority of its studies and at some time in the future NCI may transition to Rave-EDC. The contractor shall support relevant transition activities and provide professional support for RAVE-EDC as needed under a Task Order. NCI is already using Rave-EDC for some studies.
c) Hosting (Task 2) and professional services (Task 4) for approximately 19 production and test URLs, identified in Reference #1. The NCI may add new URLs or modify existing ones as needed (Task 5).
d) Professional services (Task 4):
1. To NCI contractors in support of system integration with NCI CORE applications
2. To the following NCI contractors for hosting, maintenance, and study development/management:
(1) Clinical Trials Support Unit (CTSU)
(2) Clinical Trials Monitoring Service (CTMS)
3. To ensure consistency, standardization, and best practices across the NCI multi-center URL holders (see reference #1) and the Alliance Network. Note: the Alliance has an independent contract for Rave support services. This NCI contract is limited to support for Medidata ancillary products.